EMERGENCY DEPARTMENT-INITIATED BUPRENORPHINE AND VALIDATION NETWORK TRIAL (CTN-0099). DSC5 CONTRACT. 09/20/2019 - 11/12/2022. N01DA-19-2250.

EMERGENCY DEPARTMENT-INITIATED BUPRENORPHINE AND VALIDATION NETWORK TRIAL (CTN-0099).